SMALL MOLECULES AND/OR BIOLOGICS MEDICINAL CHEMISTRY CONSULTANT SUPPORT SERVICES

SMALL MOLECULES AND/OR BIOLOGICS MEDICINAL CHEMISTRY CONSULTANT SUPPORT SERVICES

Public health relevance
Subject matter expert support for projects developing therapies for neurological disorders